MOSAIC: Biospecimen Core

SUMMARY: BIOSPECIMEN CORE
The major objective of the Biospecimen Core is to obtain, process, image, and analyze glioblastoma (GBM)
patients’ biopsies for use in both Projects of our Mayo/Columbia CSBC Mathematical Oncology Systems
Analysis Imaging Center (MOSAIC). Patient biopsies are central to our CSBC’s primary goal: building a
conceptual framework to understand sensitive response to therapy through the represented tissue states in
clinical and experimental settings. The duties of the Biospecimen Core are spread across both sites: Mayo
Clinic Arizona (MCA) and Columbia University Medical Center (CUMC).
The Biospecimen Core will assist the Center by operating under two specific aims. In Aim 1, we collect, process,
and analyze image-guided biopsies from pre-and post-treatment GBM. For Aim 2, we perform histopathological,
immunohistochemical (multiplex-IHC), and molecular analyses (bulk RNA-seq, scRNA-seq) of image-guided
biopsies.
The Biospecimen Core will provide support for both projects.
Project 1: Targeting Glioma Tissue States will utilize the RNAseq and single cell sequencing data from the
biopsies collected and analyzed by the Biospecimen Core to assess the compositional landscape of
glioblastoma along with the cross-talk between different subgroups that influence phenotype.
Project 2: Imaging the Dynamic Tissue State in Patients In Vivo will utilize the bulk histology and RNAseq
along with the imaging of the image-localized biopsies collected from the Biospecimen Core. Project 2 will
also incorporate these histologic and molecular cell lineage data into ML and mechanistic models that map the
relationship of magnetic resonance imaging (MRI) features to cellular composition. These data will drive the
training and validation of machine learning models and the parameterization of mechanistic mathematical
models.
The data generated by the Biospecimen Core will be transferred to the Data Integration and Computation
Core, where it will be stored, further processed including batch correction and atlas alignment, and integrated
into computational modeling tools.

Public health relevance
NARRATIVE: BIOSPECIMEN CORE The Biospecimen Core will assist the Center through two specific aims: Aim 1) collect and store biopsies, Aim 2) run initial tissue characterization of immunohistochemistry and sequencing. The duties of the Biospecimen Core Mayo Clinic Arizona (MCA) and Columbia University Medical Center (CUMC) and will support both projects. The data generated by the Biospecimen Core will be transferred to the Data Integration and Computation Core, where it will be stored, further processed including batch correction and atlas alignment, and integrated into computational modeling tools.